Ecology and genetics of insecticide resistance in African malaria vectors

Project summary
Title: Ecology and genetics of insecticide resistance in African malaria vectors
The current first-line vector control methods rely on pyrethroid-based long-lasting insecticidal nets (LLINs) and
indoor residual spraying (IRS). Insecticide-resistant vector genotypes are selected, leading to widespread of
insecticide resistance in sub-Saharan Africa. The evolution of insecticide resistance is threatening to reverse the
global gains in malaria control1,2. Due to the increasing insecticide resistance in sub-Saharan Africa, pyrethroid-
based synergized next generation bednets were recently introduced in many African countries to overcome the
challenge of insecticide resistance. These nets contain synergist piperonyl butoxide (PBO) which inhibits the
activity of pyrethroid detoxifying cytochrome P450 enzymes by forming a metabolite-inhibitory complex with the
enzyme. However, little is known about how African malaria vectors respond to PBO exposure at the gene
transcription, biochemical and organismal level. It has been shown that in insecticide-sensitive Drosophila that
PBO is capable of inducing the expression of the P450 and GST detoxification gene families. The increased
production of P450 and GST enzymes by PBO exposure has the potential to increase insecticide tolerance. If
this is true to malaria vectors, the impact of PBO on insecticide resistance mitigation is limited. The central
objective of this continuation application is to better understand the ecology and genetics of insecticide
resistance in the face of pyrethroid synergized nets introduction in the major African malaria vectors in
western Kenya where we maintain selected pyrethroid resistant strains and PBO nets are being widely
distributed in some counties. To achieve this goal three aims are developed. In aim 1, we will examine the
impact of next-generation PBO bednets on vector bionomics and transmission reduction. Data from this will
inform the effectiveness of PBO nets in transmission reduction in areas with pre-existing high pyrethroid
resistance. In aim 2, we will determine the genetic basis of variations in mosquito phenotypes due to PBO nets.
This aim will provide information on importance of the different mechanisms of insecticide resistance that exist
in western Kenya which is critical to the development of PBO net deployment strategy. In aim 3, we will determine
the response to PBO exposure at the gene transcription and biochemical level in pyrethroid resistant malaria
vectors. Data from this aim can provide critical information on the genetic mechanisms and risks of PBO synergist
in resistance mitigation in field malaria vector populations with high resistance. Overall, these 3 aims will inform
PBO net deployment strategy, impact on transmission reduction and potential risks on its inability to mitigate
resistance.

Public health relevance
Public Health Relevance: Malaria kills more than 400 million people in Africa each year, with the majority of fatalities occurring in children under the age of 5 in areas south of the Sahara. Control efforts have been scaled up in many parts of sub-Saharan Africa. However, these efforts are being hampered by resistance to commonly used insecticide for vector control. Results of these studies will help manage insecticide resistance and malaria control.